Acute/chronic limitations to transcriptional RNAi therapies for infectious and other liver diseases

Delivered RNAi products have now been FDA approved for treating two genetic disorders resulting from
mutations affecting genes expressed in the liver. Gene vector delivered cassettes that produce siRNAs
have an advantage for genetic disorders because of the potential for a one-shot cure. We solved one of the
mysteries of how over expression of therapeutic RNAi (transcriptional RNAi) from an AAV-U6 polII
promoter driven shRNA (AAV-shRNA) caused acute liver toxicity and continue to study this in more detail.
When siRNAs from such a source reached 12% or more of the total miRNA reads there was a 10%
reduction in the first synthesized miR122 isoform (but not the other miRNAs) and this induced acute liver
toxicity exemplified by elevated liver enzymes and in some cases liver failure and death. Because germline
knockout of miR122 has a much lesser phenotype, we hypothesize the discordance in these outcomes is
related to the differential expression of the miR122 precursor RNA transcript known as long-non-coding
RNA 122 (lnc122) and that these two RNAs have separate but coordinated functions. We propose to
elucidate the molecular function of nuclear localized lnc122 RNA and by removing lnc122 and miR122
RNAs and then reintroducing the different individual RNA components in cells, mouse liver and
hepatocellular carcinoma models. This will allow us to separate the individual functions of the RNA
products. We will also map the lnc122 chromatin interactions.
These studies are important because not only does the miR122/lnc122 gene have a tumor suppressor
function, but it is also known to have effects on normal liver regeneration, formation of hepatocellular
carcinoma, and liver fibrosis associated with various liver diseases such as NASH, lipid metabolism, and
viral hepatitis infection. Newer strategies to target gene transfer/expression outside the liver contain
transgenes with miR122 targets in the 3'UTR to exclude leaky expression in hepatocytes. This like some of
the antisense miR122 products tested in clinical trials, and hepatitis virus B and infections result in the
sponging of miR122 and the long-term effects of this are unclear. At the end of the granting period, we will
have a better understanding of the function of the various RNA products produced from the lnc122-miR122
locus and their role in cellular homeostasis and how this may effectively limit RNAi based therapeutics.
Moreover, as we learn more about the function of this genetic locus it will provide more insights into how it
participates in the disease processes noted. This may provide new insights into more optimal means to
treat patients with a variety of genetic and acquired diseases.

Public health relevance
The non-coding lnc122/miRNA122 gene locus is responsible for limiting some RNAi therapeutic approaches in the liver. We will further study the mechanism and how high concentrations of RNAi transcripts interfere with this gene locus as well as its molecular function.